Biostatistics Core

Biostatistics Core
Project Summary
The Biostatistics and Bioinformatics Core (“BB Core”) Resource will provide comprehensive biostatistics
consultation and collaboration to all Research Projects in the proposed Johns Hopkins Bone Marrow
Transplantation in Human Disease Program Project Grant. In addition, it will provide support for data storage,
informatics, and computing, and assist with the identification and solution of complex data tasks arising in the
course of project activities. Core members will work with project investigators across a wide spectrum of
activities, encompassing data acquisition (including study design, feasibility of objectives, availability of public-
access genomic information, and data storage), statistical quality control (including artifact detection and
preprocessing of data from genomic technologies), data analysis (including visualization, biostatistical modeling,
and assistance with manuscript writing), and development of innovative customized biostatistics and
bioinformatics methodologies and tools if required by specific projects. The Biostatistics Core Resource is
housed in the Division of Biostatistics and Bioinformatics, Department of Oncology at Johns Hopkins University
School of Medicine. This Division comprises an active and committed group of biostatistics and bioinformatics
faculty, as well as non-faculty biostatisticians and bioinformaticians, with access to state-of-the art equipment
and a broad range of expertise. This Core Resource is the continuation of the long-standing resource within the
ongoing BMT P01. Core members have a strong commitment to this P01, stemming from more than 30 years
of collaboration with the BMT program. All proposed Projects make use of this Core Resource in every Aim.
The primary objective of the BB Core is to guide and assist the project investigators in the design, conduct,
and analysis of the laboratory and clinical studies proposed in this P01. This core is led by Dr. Ravi Varadhan,
Associate Professor, Oncology Biostatistics and Bioinformatics. The Core focuses its efforts on assisting both
the clinical and laboratory investigators in translating their pre-clinical studies into clinical studies by providing
state-of-the-art experimental designs and analyses through statistical consultation and collaboration with
respect to methodology, feasibility, safety monitoring, analysis, and reporting of clinical and laboratory studies.
For more than 30 years, the BB core has been and continues to be an integral part of the research
accomplishments of the individual projects of this P01 application.

Public health relevance
Biostatistics Core Project Narrative The Biostatistics and Bioinformatics Core (BB Core) serves as a centralized resource to all BMT P01 program investigators and promotes synergy across different projects and resources. It enhances the abilities of projects to address key translational questions that will lead to a reduction in the morbidity and mortality associated with hematologic malignancies. The work of the BB Core is to ensure that clinical and laboratory studies are carried out using sound designs, and the results analyzed with appropriate methods in order to obtain valid scientific inferences.